2023 RNA Nanotechnology Gordon Research Conference and Seminar

PROJECT SUMMARY
This R13 application requests partial funding to support the upcoming Gordon Research Conference (GRC) on
RNA Nanotechnology, which will be held in Ventura, CA on Jan 8-13, 2023, and the associated Gordon Research
Symposium (GRS), to precede it on Jan 7-8. The meeting will be co-chaired by Louise Laurent and Sarah
Woodson, who were elected at the second GRC on RNA Nanotechnology in January 2017 and served as the
co-vice chairs of the third GRC in January 2019. The conference planned for 2021 was postponed by the GRC
due to the COVID pandemic. RNA nanotechnology continues to grow as an important field, with active research
being carried out to elucidate basic principles of and develop innovative approaches to the design and
construction of a variety of RNA nanostructures, as well as exciting work applying RNA nanotechnology to solving
problems in biotechnology and medicine. The pace of discovery and innovation has only accelerated in the past
two years. RNA nanotechnology is built upon unique properties of RNA, including structural versatility, existing
biological functions, and ease of functionalization, which make it an ideal platform on which to build complex
self-assembling architectures with a variety of functional attributes for diverse applications. This GRC focuses
on linking fundamental studies on the mechanisms of RNA structure, assembly, and packaging to translational
work using RNA nanotechnology in imaging, diagnostics, and therapeutics.
The meeting will cover a range of topics in nine sessions. Sessions on RNA Modifications & Biotypes, RNA
Structure & Assembly, and Synthetic & Programmed Nucleic Acid Assemblies will feature cutting-edge research
on the molecular basis of nucleic acid architectures, design and characterization of nucleic acid nanostructures,
and biophysical approaches to study and predict RNA folding. Emerging new applications of nucleic acid
architectures as functional devices and as control elements in synthetic biology will be presented in sessions on
RNA Aptamers & Riboswitches and RNA Imaging. Sessions on RNA Encapsulation & Delivery, RNA Cargo
Selection in extracellular vesicles, RNA-based Biomarkers & Diagnostics, and RNA Therapeutics will provide
perspectives on discovery, isolation and application of RNA from extracellular vesicles and viruses with an
emphasis on translational aspects of natural and synthetic RNAs in development of diagnostics and therapeutics.
The 2023 conference will continue to emphasize robust representation of women and minority scientists. The
invited speakers and discussion leaders will include a mix of established researchers in the field and outstanding
junior-level investigators from around the world. The meeting will be advertised to a diverse audience to include
early career and under-represented minority scientists in the RNA nanotechnology and related fields. A Power
Hour will feature topics of inclusion and opportunity.

Public health relevance
PROJECT NARRATIVE The accelerating field of RNA nanotechnology takes advantage of the structural and functional versatility of RNA to design and construct complex nanostructures that can be used for research and clinical applications. The 2023 Gordon Research Conference on RNA Nanotechnology will provide a forum for interdisciplinary interactions among scientists from diverse backgrounds and expertise, with a special emphasis on integrating junior scientists. The conference program aims to link fundamental research on RNA structure, design, and extracellular vesicle biology with applications of RNA nanotechnology for metabolic engineering, screening, diagnosis, and RNA-based therapeutics and vaccines.